CranioRate: An imaging-based, deep-phenotyping analysis toolset, repository, and online clinician interface for craniosynostosis

PROJECT SUMMARY
Title: CranioRate™: An image-based, deep-phenotyping analysis toolset, repository, and online
clinician interface for craniosynostosis.
The purpose of this research grant application is to build on the advanced machine learning (ML) tool
developed as part of a pilot study (R21EB026061) that objectively quantiﬁes cranial dysmorphology, or
deep phenotypes, in patients with metopic craniosynostosis (MC). Abnormal cranial suture fusion
(craniosynostosis) occurs in one of every 2500 infants born in the US, resulting in disrupted regional
skull growth and an increased risk of elevated intracranial pressure, neurocognitive impairment and
visual disturbances including blindness. Impaired skull growth along the fused suture and subsequent
growth compensation in other areas of the skull lead to predictable head shape patterns in patients with
craniosynostosis; surgery is recommended early in childhood to restore normal head shape and
prevent neurocognitive sequelae.
In our work to date, our team has developed an ML/statistical shape analysis system utilizing computed
tomography (CT) scans of patients with MC. We have demonstrated that our deep ML algorithm is as
effective as expert clinician ratings in assessing severity and more effective than standard craniometric
tools. We have expanded our processes to include the analysis of 3D photography to increase
accessibility and study post-operative head shape. Thus far, we have demonstrated equivalent severity
ratings between 3D photographs and CT scans when obtained on the same patients. Finally, we have
designed and implemented an online head shape portal (CranioRate™) that automates preprocessing
and analysis such that users can upload their own patient images, where the resulting data contributes
to clinical patient care as well as research endeavors. To date, over 30 clinicians have contributed
almost 400 MC CT scans to our portal, making our metopic craniosynostosis imaging collection the
largest reported.
In the proposed work, we will reﬁne our processing pipeline and shape analysis technologies, while
expanding our capabilities to encompass all forms of craniosynostosis and a wider array of imaging
modalities, and improve the functionality and security of the CranioRate™ portal. To pursue these aims,
we will bring together a robust consortium of collaborators to contribute imaging and clinical data,
empanel a scientiﬁc advisory board to ensure data integrity, and establish an open access human
craniosynostosis image bank to allow further collaborations through FaceBase. Speciﬁc goals for the
current project are to: 1) Further develop a set of robust, general morphological quantiﬁcation
technologies and cloud-based implementations that result in effective scientiﬁc and clinical tools; 2)
Establish a shared-access, well-curated dataset that will leverage our multicenter collaborative network
and partnership with FaceBase; 3) Identify and collect pertinent clinical data to extend the utility of our
shape analysis tool and shared-access database. The results of this study will signiﬁcantly improve the
understanding of the phenotypic variation in patients with craniosynostosis and will pave the way for
more substantial imaging-based research in this understudied population.

Public health relevance
PROJECT NARRATIVE This grant proposal aims to improve our understanding of craniosynostosis by expanding on our prior work using machine learning methodologies to objectively quantify the head shape anomalies in this condition. During the project, we will further develop a point-of-care tool, CranioRate™, to allow physicians to improve their understanding of their patients and create an accessible collection of imaging data so researchers can more easily study this challenging population of patients. With this information, surgeons will be able to better tailor their interventions to the needs of their individual patients, and researchers will improve their understanding of this complex disorder.